Glial Origin and Signaling in Medulloblastoma

Summary of Proposed Research
Medulloblastoma (MB) represents the most common malignant childhood brain tumor. Despite
aggressive multimodal therapy, the prognosis for many MB patients is grim: nearly half succumb to
the disease following tumor recurrence, generally a fatal event for these patients. This presents an
urgent need for novel therapeutic modalities that target the relapse-initiating cells and their growth
at the root of tumor recurrence, and improve patient survival while minimizing adverse side effects.
By using single-cell analysis of MB tumor tissues, we identify a population of transit-amplifying
progenitors expressing Olig2, which marks glial progenitors and oligodendroglial precursor cells
during neural development, as a prominent tumor-initiating/propagating population during the early
phase of MB tumorigenesis. Strikingly, OLIG2 expression is upregulated in relapsed tumors in
animal models of sonic hedgehog (SHH)-MB after chemotherapy and human recurrent MBs,
suggesting a potential role for glial progenitors and their underlying fate determinants in MB tumor
recurrence. Although acquisition of the neuronal progenitor identity is critical for SHH-driven MB
formation, which could reflect growth or progression, the contribution of glial progenitor cells during
tumor recurrence remains elusive.
We hypothesize that a population of glial progenitors are intermediate progenitors predisposed
to the transformation before transition to neuronal progenitors in MB initiation and recurrence, and
that glial specification factors-mediated core regulatory pathway are a hitherto undiscovered MB
tumor-promoting cues that may serve as a potential therapeutic target for MB recurrence. Given
that glial progenitors may represent a novel tumor-initiating cell in malignant and recurrent MB, in
this proposal, we will dissect tumor heterogeneity, evolution, and microenvironment during tumor
recurrence and test the hypothesis that glial progenitors are critical transit-amplifying cells that
initiate tumor recurrence. In addition, we will define signaling mechanisms and characterize glial
fate determinants-mediated regulatory circuits that drive MB recurrence through genetic and
pharmacological approaches. Thus, these proposed studies should advance our understanding of
the cells of origin for tumor recurrence and underlying pathogenesis at molecular and cellular
levels, and facilitate devising new, effective strategies to treat these deadly pediatric brain cancers.

Public health relevance
Project Narrative The work proposed will provide a better understanding of tumor relapse by exploring a glial origin for recurrence in medulloblastoma, the most common malignant pediatric brain tumor, and identify critical pathways that drive tumor relapse in medulloblastoma. It will not only have scientific merit for general understanding but is also likely to be of practical value in treating patients with the devastating childhood brain tumors and brain tumor-associated cognitive dysfunction and dementia.